Data Management and Biostatistical Analysis Core

Data management and biostatistical analysis are critical to the success of clinical, epidemiologic and
translational research. Despite this, these two disciplines are frequently overlooked and under-resourced
during research planning and execution. Sub-optimal data collection and management approaches can
generate missing and inaccurate data; researchers may be unaware of such issues in their data, which may
be irreparable or require considerable resources to retrospectively repair. Deficiencies in biostatistical
analysis are common and are also frequently unrecognized by non-experts. In resource-limited settings
such as East Africa, research is even more susceptible to data management and biostatical analysis
problems due to the absence of well-trained personnel and appropriate funding for high-level data
management and biostatistical analysis. The result is a biomedical research system that often relies upon
sub-optimal data management and analytic approaches performed by individuals with less than optimal
training. Our goal is to transfer relevant technology and approaches to East Africa by making these available
to our Research Projects and investigators within one efficient shared resource core. The Data
Management and Biostatistical Analysis Core (DMBAC) of United States-East Africa HIV-Associated
Malignancy Research Center (USEAHAMRC) will therefore have the following specific aims:
Aim 1. Provide expertise and a common platform for primary data collection and data
management as well as specialized instruction to our junior scientists.
Aim 2. Offer project-specific biostatistical support both during the planning of new research and
during the analysis of ongoing studies as well as specialized instruction to our junior scientists.
We will leverage the expertise in data management and biostatistical analysis built at the Department of
Epidemiology and Biostatistics at UCSF over the past two decades — and particularly during U54
CA190153 — and use it to support our two Research Projects and Pilot Projects. The core will also provide
focused high-level didactic instruction in data management and biostatistical analysis through the Career
Development Seminar organized by the Developmental Core. This will allow our emerging African principal
investigators to incorporate best practices into their current and future studies, communicate effectively with
data managers and biostatisticians, and keep abreast of developments in technology and methodology. By
offering assistance from faculty-level biostatisticians who are familiar with the substantive aspects of HIV
infection and HIV-related malignancies, we will ensure that the USEAHAMRC meets these objectives.

Public health relevance
This project will establish a network of scientists from the U.S., Uganda, Kenya, and Tanzania to study cancer in the context of HIV infection in sub-Saharan Africa. This research requires large amounts of data, which will need to be properly collected, organized, and analyzed. We will facilitate this process by creating a group with centralized expertise in data management and statistical analysis to assist our research projects and junior scientists from both the U.S. and East Africa as they continue to progress in their scientific careers.